Phase 1 Clinical Trial of CMS121, a Novel Therapeutic Candidate for Alzheimer's Disease

Abstract
The parent grant for this application supports a Phase I clinical trial of CMS121, a small molecule that
has shown efficacy in multiple mouse models of Alzheimer's Disease and which affords a different
therapeutic approach for treatment of AD in humans. In this application we request supplemental funds to
cover the costs of COVID-19 mitigation procedures and COVID-19 testing of trial subjects. These
processes and associated costs were not necessary at the time of application due in large part to the
rollout of highly effective vaccines and declining infections but have become essential now due to repeated
surges in infections and the appearance of highly infectious variants of the virus. The mitigation and
testing procedures are necessary to protect the clinical and non-clinical staff, as well as trial subjects at the
clinical site from COVID-19 infection.

Public health relevance
Narrative Currently there are no drugs that can prevent, slow or stop the progression of Alzheimer's disease. The parent grant for this request for supplemental funds supports the conduct of a Phase 1 clinical trial to advance a novel compound that is both neuroprotective and able to prevent the loss of brain function in Alzheimer's disease. If successful, this approach could prove beneficial for the treatment not only of Alzheimer's disease but also a number of other age-related disorders. The supplemental funds are to provide COVID-19 mitigation and testing procedures to protect trial staff and subjects from infection by COVID-19.